MECHANISM OF VASCULAR REGULATION IN CONGESTIVE HEART FAILURE

The purpose of this research is to characterize plasma EDRF and endothelin levels in patients with CHF, and to determine whether angiotensin plays a role in modulating EDRF and endothelin in such patients.